Differences Among Older English and Spanish-speaking Latinx Patients with Type 2 Diabetes at Risk for Hypoglycemia (Admin Supp)

Project Summary
Many older adults with type 2 diabetes (T2D) experience dangerous hypoglycemic due to intensive T2D
medication treatment.1,2 The decision to reduce treatment intensity must be informed by patient preferences
and values.3 New tools that educate patients and build their communication skills to voice their preferences
offer a promising strategy for improving the safety of T2D care in high-risk older adults.4,5 The goal of this R01
award is to apply principles of values elicitation and skill building for communication and decision making to the
specific clinical problem of hypoglycemia-related adverse outcomes in vulnerable older patients. The aims of
the parent R01 are to develop an online tool to specifically address T2D treatment intensity in older adults at
increased risk for hypoglycemic events, and to then conduct a randomized trial to assess the efficacy of this
new tool to reduce hypoglycemia events among high-risk patients  75 years of age. Our approach to support
value-aligned care represents an innovative and potentially widely applicable method to help older adults to
make informed decisions based on their goals and preferences.6 If successful, this framework could be scaled
and applied in a wide variety of healthcare settings and chronic conditions in which evolving risks, benefits, and
consequences of treatment require re-assessment with age. The addition of Clarissa Ferguson through this
Administrative Supplement will provide the project with the excellent opportunity to conduct analyses of older
Hispanic/Latinx participants who would otherwise be eligible for our clinical trial (approximately 29% of
expected participants, similar proportion to the source population in Northern California).7 She will examine the
similarities and unique differences in how older Hispanic/Latinx patients with type 2 diabetes versus adults
from other race/ethnicities engage with the health care system and their current medication-related practices.
Further study focused on older Hispanic/Latinx patients has the potential to provide useful insight into how to
best engage this patient population in research designed to improve engagement and reduce medication risk.8
The proposed research is directly related to the main goals of the parent grant while also broadening our
project by extending our comparative analyses of Hispanic/Latinx patients. This study addresses the three NIH
priorities of translating evidence into practice, improving medication safety, and understanding health care
disparities. The specific project proposed within the Under-Represented Minority (URM) Administrative
Supplement will focus on the examination of older Hispanic/Latinx patients with type 2 diabetes at increased
risk for hypoglycemia. This supplemental work will provide further insight into the potential disparities and
unique barriers to communication faced by older Hispanic/Latinx patients during primary care visits.

Public health relevance
Project Narrative Treatment-related hypoglycemia is a growing and dangerous problem among older patients with diabetes.14 Efforts to appropriately reduce treatment intensity require new tools to help patients and providers weigh the risks and benefits.4,5 We propose to implement and evaluate a new tool to educate patients and build their communication skills to voice their preferences related to diabetes treatment intensity. The additional work of this proposed URM Administrative Supplement will broaden the reach of the parent R01 to include an examination of the experiences of older Hispanic/Latinx patients.